GENETIC CONTROL OF MURINE LEUKEMIA VIRUSES AND VIRUS-INDUCED NEOPLASMS

This project covers studies aimed at expanding our understanding of the pathogenesis of murine leukemia virus (MuLV)-related disease, especially the various genetically specified mechanisms involved in determining sensitivity and resistance of inbred mice to infection and disease induction. Two major areas are under study, one involving exogenous infection of adult mice by the replication defective MAIDS MuLV and replication competent MuLVs, and the second studying the hematopoietic tumors developing spontaneously in NFS V-congenic mouse strains which carry on the virus-negative, low lymphoma NFS background germ-line integrations of ecotropic MuLv derived from the high virus, high thymic incidence AKR and C58 strains. We have described both MHC Class I and Class II effects on sensitivity and resistance to MAIDS, with a major control deriving from H-2 haplotype. We are now studying genes outside the MHC complex that modify disease and may or may not affect helper virus replication. After extensive strain sensitivity testing, we have established matings and tested progeny of several resistant and sensitive pairs and are utilizing microsatellite DNA mapping to score for genetic markers associated with degree of permissiveness to MAIDS induction and to helper virus replication. In studies of V-congenic mice, lineage relationships established for about 300 tumors indicate that the majority are B cell; 40% of tumors ar lymphoblastic or small lymphocyte tumors, 83% of which are of B cell lineage. Over 20% of B cell lymphomas appear to be of splenic marginal zone origin. The majority of tumors tested have new clonal ecotropic MuLV integrations compared to control tissue. Of related interest, in some V-congenic families a surprisingly high level of new clonal proviral integrations has been detected.